Opioid-Sparing Interdisciplinary Interventions Addressing Pain in Head and Neck Cancer Patients

PROJECT SUMMARY
BACKGROUND: For patients with head and neck cancer receiving radiation therapy (HNC), the frequency of
substantial pain may be as high as 60 to 90% due to both the disease and its treatment. In the face of the
opioid crisis, there has been a universal push for opioid-sparing treatments in patients with pain; however, this
is not a viable option for most HNC patients experiencing pain, as there remains a lack of alternative pain
control modalities. Our preliminary data suggest that in HNC patients, there is a higher risk of non-medical
opioid use (NMOU) and a higher frequency of positive CAGE (Cut Down, Annoyed, Guilty, and Eye opener)
scores. The high NMOU risk exposes patients and their families to harm, but patients still need effective pain
relief. There is, therefore, a critical need to find new and effective methods for management of pain in patients
with HNC who have a high risk of NMOU. This proposal will focus on two promising interventions targeting
different underlying mechanisms of NMOU. CHAT (Compassionate High Alert Team) is an intensive,
manualized, interdisciplinary, and patient-centered approach to manage patients with a high risk of NMOU.
Neurofeedback (NFB) has shown promise in controlling pain and concomitant psychosocial aspects of pain.
However, to date there are no studies of NFB for NMOU risk behaviors in cancer patients receiving treatment.
OBJECTIVES: The long-term objective of this work is to devise effective strategies to manage cancer patients
with NMOU behaviors, but who must be prescribed an opioid to treat their pain.
SPECIFIC AIMS: 1. To test the hypothesis that this study will be feasible, as defined by adequate rates of
adherence in the CHAT and NFB groups. 2. To examine the frequency of NMOU behaviors at the end of 3
months after CHAT, NFB, and SOC. 3. We will examine the pain severity [area under the curve (AUC)] and
daily opioid use [AUC of the cumulative morphine equivalent daily dose (MEDD)] for each of the treatment
arms (CHAT, NFB, or SOC) in HNC patients at the end of 3 months. 4. To examine the cortical and subcortical
regions of the brain associated with pain and our interventions (CHAT, NFB, and SOC) and the extent to which
changes in EEG patterns mediate the effects of the intervention.
RESEARCH DESIGN: This will be a Phase 2 randomized controlled trial. Patients with HNC will be screened
for evidence of NMOU risk and offered the opportunity to participate in the study if they screen positive. Patients
will be randomized to either CHAT, NFB, or SOC. We will assess the feasibility, change in frequency of NMOU
behaviors, change in pain severity [area under the curve (AUC)] and daily opioid use AUC of the cumulative
morphine equivalent daily dose (MEDD) at the end of 3 months after CHAT, NFB, and SOC. Finally, the
exploratory aim in this proposal will generate exciting new insight into the problem of pain, NMOU behavior, and
mechanisms of CHAT and NFB. This study could identify two novel patient approaches to NMOU management,
CHAT and NFB, with the potential to positively impact the lives of cancer patients across the U.S. and worldwide.

Public health relevance
PROJECT NARRATIVE Between 60 and 90% of head and neck cancer receiving radiation therapy patients will experience substantial pain that requires opioids for relief, but prescription of opioids for these patients, who often have a higher risk of NMOU, exposes them to the potential for increased harm. Based on prior studies by our team, the goal of this proposal is to determine the effects of our group’s Compassionate High Alert Team intervention or a Neurofeedback intervention on daily opioid use, engagement in NMOU, quality of life, mood, cancer-related symptoms including pain, and improvement of health utilization outcomes over a 3-month period. This study has the potential to identify novel opioid-sparing treatments for patients with HNC and a high-risk of NMOU, allowing these patients to benefit from adequate pain control while reducing their risk of NMOU and other adverse outcomes.